Optimizing population oral health through integrating patient, provider, and population-based approaches

PROJECT SUMMARY/ABSTRACT
The goal of this research program is to optimize population oral health through strengthening the scientific basis
for innovations in population approaches to improving dental care access, utilization, and quality for all
Americans. Mounting evidence suggests that oral and dental conditions in the US are largely attributed to
population-specific differences in access to, utilization of, and the quality of oral health care services. These
differences arise from system-wide interactions between biological, psychological, social, environmental,
economic, policy, and other factors. While there is increasing awareness of these complexities, meaningful
scientific progress and translation is stymied by the preponderance of investigations that maintain a focus on
individual, single-level factors in isolation. This research program incorporates a framework that integrates multi-level perspectives and approaches (e.g., patient, provider, and population) to optimize oral and dental health,
facilitated by the PI’s expertise as an epidemiologist and complex systems scientist. Specifically, the research
program will generate novel data on US populations and employ methodologies to conduct innovative
investigations situated at the intersections of dental care access, utilization, and quality. Findings will be
leveraged to develop comprehensive, cost-effective policies and strategies to provide high-quality dental care
and optimize oral health for all Americans.

Public health relevance
PROJECT NARRATIVE This program of research aims to identify and investigate the individual and synergistic causal mechanisms of oral and dental disorders, including biopsychosocial risk factors and dental care access, utilization, and quality. Increased understanding of the multi-level mechanisms that shape health and disease at the population level will facilitate the optimization of efficient and cost-effective oral and dental health programs, policies and practices.